Mammal-microbial coevolution: mechanisms and health implications

PROJECT SUMMARY
The goal of my research program is to investigate the mechanisms of mammal-microbial coevolution and its
implications for host health, with a focus on codiversification—the parallel evolutionary history of host and
microbial lineages. The microbiome has emerged as a key therapeutic target, and disruptions in these
coevolved relationships are linked to adverse health outcomes, including immune, metabolic, and behavioral
changes. However, the mechanisms underlying codiversification and the health impacts of losing vertically
transmitted microbes in mammals remain unclear. As human migration and translocation increase, populations
are exposed to novel microbes, making it crucial to predict host-microbial interactions in changing
environments. Over the next five years, we will utilize Peromyscus spp. (deer mice) in the Arizona Sky
Islands—an isolated system where mouse populations diverged similarly to major human populations—to
disentangle the mechanisms of codiversification across various temporal and spatial scales. This natural
experiment, combined with laboratory experiments, provides a unique model to assess how codiversification
influences host phenotypes. The research will address three major knowledge gaps: (1) Identify codiversified
microbial taxa and traits across body sites (skin, vaginal tract, small intestine, and feces), populations, and
species; (2) Investigate mechanisms driving codiversification, specifically whether host filtering or dispersal
limitation governs microbiome assembly; and (3) Assess how disruptions in codiversification affect host health
by measuring changes in immune response, metabolic function, and behavior. We will generate whole-genome
and metagenomic sequencing data to construct phylogenies for both host and microbial lineages and identify
key microbial taxa and traits that are passed across generations. A key challenge will be distinguishing host
filtering from dispersal limitations in shaping evolutionarily stable host-microbial associations. However, our
comprehensive sampling design, manipulative laboratory experiments, and new bioinformatic tools provide a
rigorous framework to tackle this issue. Fecal transplant experiments will offer the first description of
mammalian phenotypes in response to host population- and species-level differences in microbiomes,
addressing critical knowledge gaps and motivating future research. These findings have significant implications
for the development of microbiome-based therapeutics tailored to specific host genotypes and ancestries,
supporting a precision medicine approach.

Public health relevance
PROJECT NARRATIVE This research will investigate how disruptions in long-term host-microbial association affect health outcomes in mammals. By focusing on deer mice (Peromyscus spp.) as a model, we will identify microbial species and traits passed across generations and assess how the loss of these microbes impacts immune, metabolic, and behavioral traits. These findings will help inform precision medicine by developing therapeutic strategies tailored to individual genotypes and ancestries.